Cognitive Neuroscience of Development and Aging (CoNDA) Center

The CoNDA Center at the University of Nebraska Medical Center (UNMC) is dedicated to advancing our understanding of neurocognitive impairments in both development and aging. As the prevalence of disorders like Autism Spectrum Disorder and Alzheimer’s disease continues to increase, the Center's mission becomes increasingly relevant. Building on the success of Phase I, Phase II of the Center's efforts aims to further bolster multidisciplinary research and collaboration. This will be achieved by building upon the following efforts: (1) recruiting highly qualified faculty, as top-tier talent is essential for driving innovative research forward. By bringing in exceptional researchers, the Center ensures a wide range of expertise to tackle complex questions in neurocognitive impairments; (2) maintaining a robust Administrative Core and mentoring program, which is crucial for supporting the development and success of faculty members, particularly our recruits. The mentoring infrastructure provides guidance, resources, and support to help researchers thrive in their roles; and (3) continuing to enhance CoNDA’s Research Cores. Investing in state-of-the-art scientific Research Cores is essential for expanding the Center's research capacity. By providing access to cutting-edge technologies for neuroimaging and behavioral assessment in both human subjects and animal models, the Center empowers researchers to conduct high-quality translational research. Through these initiatives, the CoNDA Center aims to advance scientific knowledge and support its researchers' career advancement. By fostering a collaborative and supportive environment, the Center positions itself as a leader in the field of cognitive neuroscience, with the potential to make significant contributions to our understanding of neurocognitive impairments across the lifespan.

Public health relevance
Neurocognitive disorders are some of the most prevalent and disabling conditions worldwide. This application requests Phase II support for a successful COBRE in Cognitive Neuroscience in Development and Aging. Four distinct projects study sleep impairments in Alzheimer’s disease, a high-risk autism gene, brain signal synchrony in dementia patients and caregivers, and deficits of emotional perception in of Parkinson’s disease. These will contribute to our knowledge of mechanisms and impact of neurocognitive disorders. Core facilities provide support for neuroimaging and behavioral assessment in humans and non-human animals.